Biostatistics

PROJECT SUMMARY/ABSTRACT
The Biostatistics Shared Resource (Biostats) is an integral component of the Laura and Isaac Perlmutter
Cancer Center (PCC) that provides state-of-the-art statistical collaboration and consultation to PCC members
across the entire spectrum of the research process, from basic and translational investigation to clinical trials to
observational and population-based research. Judith D. Goldberg, ScD, Professor of Biostatistics in the
Department of Population Health leads Biostats, with Co-director Judy Zhong, PhD, Professor of Biostatistics,
and senior faculty member Yongzhao Shao, PhD, Professor of Biostatistics. Two additional faculty and three
research staff in the Division of Biostatistics at NYU Grossman School of Medicine (NYUGSoM) participate to
provide statistical support dedicated to PCC members. Biostats collaborates with all PCC Research Programs,
with PCC Disease Management Groups, and with other PCC Shared Resources (SR). We provide statistical
expertise in research study design, conduct, analysis, interpretation, and reporting of results for laboratory
studies (in vitro, in vivo), clinical trials, and observational studies, including population-based studies. Biostats
faculty have developed and continue to develop methodologies that are central to new directions in laboratory-
based, clinical, translational, and population-based cancer research. We also provide education on statistical
concepts and study design to members and their collaborators. During the current funding period, Biostats
supported 34 active extramurally funded grants (26 with salary support), and contributed to 111 collaborative
and methodologic publications in leading journals. Biostats, like other SRs, is overseen by the Division for
Advanced Research Technologies (DART), has an Advisory Board, and is subject to annual surveys to ensure
alignment with PCC needs. The Specific Aims of Biostats are: 1) to provide state-of-the-art statistical
collaboration and support in the design, conduct, analysis, interpretation, and reporting of basic, translational,
clinical, and cancer-related epidemiological and prevention research, 2) to support the PCC Clinical Trials Office
for informatics, clinical protocol development and implementation, data management processes and procedures,
and data safety monitoring, 3) to develop innovative statistical methods and approaches to address new research
directions of PCC members, in areas that include, but are not limited to, the design and analysis of translational
studies, statistical genetics and genomics, and emerging technologies, and 4) to provide training and mentoring
to PCC members and staff in statistical concepts related to study design, analysis, and interpretation of all types
of cancer research studies.